Data Management for Molecule Simulation : A Throughput-Oriented Approach

Project Summary
This is an administrative supplement to the parent R01 project GM140316 titled “Data Management for Molecule Sim-
ulation: A Throughput-Oriented Approach." The main objective is to acquire a parallel computing server that hosts 4
NVidia H100 GPU cards, two Intel Xeon Platinum 8480+ 28-core CPUs, 2TB of DDR5 system memory, and 64TB of
NVMe M.2 internal storage. We believe this will be an essential component that leads to the success of the proposed
research tasks in the parent grant. Speciﬁcally, the new server will provide the following capabilities that are not found
in existing computing facilities the project team has access to: (1) and Memory Capacity: With 37-64 petaFLOPs of to-
tal in-core computing power, 320GB of GPU memory with a bandwidth of 3.35TB/s, the server can signiﬁcantly improve
Speciﬁc Aim 2 tasks by reducing the time for processing analytical queries against molecular dynamics (MD) simula-
tion data; (2) Storage Capacity: we propose to use NVMe devices with 64TB of space to store datasets and associated
metadata, with 1.2 million IOPS and 48GBps of total bandwidth. This will allow low latency access to large datasets for
processing, which is required by tasks in Speciﬁc Aim 3; (3) Data Communication: the H100 GPUs are connected by
NVidia's 4th-generation NVLink buses, allowing non-blocking bidirectional communication between GPUs with a total
bandwidth of 900GB/s. This will speed up large-scale MD simulations by releasing the GPU-to-GPU data transmission
bottleneck, affecting Speciﬁc Aim 4 of the parent project.

Public health relevance
Project Narrative We propose the acquisition of a compute server equipped with NVidia's H100 GPUs as an experimental platform for the high-performance parallel and distributed algorithms and software systems developed in research tasks of parent R01 project titled “Data Management for Molecule Simulation: A Throughput-Oriented Approach." This equipment can signiﬁcantly improve throughput and latency of post-simulation data analysis and active in-simulation control of MD studies. It will also beneﬁt the study of the structure, dynamics, and thermodynamics of biomolecules, demonstrating impacts on application domains such as discovery of new medicines, biomimetic material design, and pathology/diag- nosis of genetic diseases.